Macrophages and fibroblasts in the progression of lung cancer

Lung cancer is the leading cause of death in the United States, with over 125,000 patients predicted to die of
lung cancer in 2024. Despite improvements to treatments, such as advancements in immune therapy, patients
diagnosed at late-stage diseases have low response rates to therapies across the board. Aside from
immunotherapies, there are few therapies that target the stromal components within the tumor
microenvironment. Macrophages and fibroblasts have been shown to be some of the most abundant stromal
cell types in tumors and have been found to contribute to immune suppression in the tumor microenvironment.
To better understand how macrophages and fibroblasts contribute to immune suppression, In Aim 1, I will
adapt CRISPR/Cas9 mediated gene editing to inactivate ~50 genes in macrophages in vivo and track
macrophage phenotypes throughout lung cancer tumor progression. In Aim 2 I will inactivate ~50 genes in
fibroblasts in vivo, tracking phenotypes and identifying important pathways in fibroblast that drive tumor
progression. In Aim 3 I will determine how our top candidate genes in macrophages and fibroblast impact the
large tumor microenvironment and functionally determine how they contribute to immune suppression. This
study will elucidate stromal cell phenotypes of importance at various stages of tumor progression and has the
potential to reveal new stromal targets to improve immunotherapies in lung cancer.

Public health relevance
While treatments like immunotherapy have improved, late-stage patients often don’t respond well. Few therapies target macrophages and fibroblasts within the tumor, despite evidence suggesting these cell types contribute to tumor progression. This K00 project will use in vivo gene editing of macrophages and fibroblasts to identify immune suppressive phenotypes and pathways contributing to lung cancer tumor progression.